A concise dearomative approach to the synthesis of quinolizidine natural products

Project Summary/Abstract
Whereas the piperidine motif is ubiquitous in pharmaceuticals, higher-order N-heterocycles such as
quinolizidines and indolizidines are more challenging to prepare. This can limit their incorporation into drug
development, despite their prevalence in important biologically active natural products. Dearomatization
reactions offer a unique entry into these natural products, rapidly building complexity from accessible aromatic
starting materials. Pairing this powerful strategy with stereodefined cyclization cascade reactions enables an
orchestrated assembly of the oxidized fused ring structures present in many alkaloid targets. This proposal
describes the development of an enantioselective dearomative cyclization to synthesize quinolizidines in one
step from pyridine, grounded in the hypothesis that palladium can be used to kinetically trap a reversibly forming
acyl chloride to synthesize enantioenriched quinolizidines through a dynamic kinetic resolution. To accelerate
the development of this strategy, modern data science techniques will be applied to high-throughput datasets,
enabling rapid traversal of the multidimensional and potentially complex optimization landscape. These studies
are expected to provide a workflow for the future development of reaction cascades through machine learning,
enabling practitioners to develop kinetically complex reaction landscapes that might otherwise seem intractable
but provide opportunities to dramatically build molecular and synthetic complexity. This approach will be
showcased in an asymmetric synthesis of lycopodine and lycoposerramine H, natural product inhibitors of
acetylcholinesterase—a property that is therapeutically relevant for the treatment of neurodegenerative
disorders. We expect that the flexible synthetic approach proposed could apply to future diversity-oriented
synthesis campaigns around this natural product family towards the development of small molecule
neuroprotective drugs, as well as more broadly to the synthesis of stereodefined, bioactive alkaloid skeletons.

Public health relevance
Project Narrative Fused piperidine structures, such as quinolizidine and indolizidine motifs, feature prominently in small-molecule therapeutic targets with neuroprotective, anti-protozoal, and anti-cancer properties—all of which serve immediate public health and biomedical priorities. However, even relatively simple fused scaffolds can require laborious synthetic work to prepare, hampering development in this area. This proposal outlines the high- throughput, data-driven development and application of asymmetric 3-component Pd cross-coupling reactions for the rapid assembly of fused alkaloid skeletons, including for the total syntheses of lycopodine and lycoposerramine H—natural products with potential neuroprotective properties.